Training Program in Endocrinology, Diabetes, and Metabolism

PROJECT SUMMARY
This proposal seeks continuation of support for the Training Program in Endocrinology, Diabetes, and
Metabolism (EDM) at Cedars-Sinai Medical Center. Consistent with the 17-year history of this program, our
goal is to train postgraduate scientists and physician-scientists in the study of thyroid disorders, reproductive
endocrinology, diabetes/metabolism, endocrine oncology, endocrine hypertension, and neuroendocrinology.
Under the guidance of Shlomo Melmed, MD, and Richard Bergman, PhD, 20 Faculty Preceptors, 50% of whom
are female and 35% of whom are junior faculty, will guide our trainees for investigative careers in endocrinology
through curriculum-based instruction, intensive research training, multidisciplinary interactions, and interactive
translational research. Our Faculty Preceptors are a strength of this program, with $21 million dollars in funding
per year, and their productivity led to 1336 publications over the last ten years by our trainees. We will continue
this success with program improvements, including expanded areas of research, improved program
assessment and tracking, increased trainee recruitment from underrepresented minorities, and addition of
senior faculty to mentor junior preceptors and enrich their mentorship experience. We are requesting funding
support for three postdoctoral positions in our quest to accelerate training for translational discovery in EDM
research.

Public health relevance
PROJECT NARRATIVE Endocrinology-related diseases are a major area of health concern for today's society. For the past 17 years, the Training Program in Endocrinology, Diabetes, and Metabolism at Cedars-Sinai Medical Center has successfully addressed the specialized training of scientists in several areas of endocrinology research, including diabetes and obesity, endocrine oncology, and neuroendocrinology. Continuing this program for another five years will enable us to continue training postdoctoral scientists and physician-scientists in this important area.